Mechanism and effect of exenatide on weight loss: Randomized controlled trial

Volunteers are screened and admitted to our inpatient clinical research unit. They undergo baseline measurements of glucose tolerance, food intake and energy expenditure in a whole room indirect calorimeter. After randomization to active drug or placebo, these measurements are repeated. After the baseline admission, volunteers are followed as outpatients initially on a weekly basis (for one month), followed by a monthly basis for another 5 months. Volunteers are then readmitted for repeat measurements of food intake. All volunteers have the option of open label use of exenatide for another 6 months during which time they will again be followed monthly. Our goal is to recruit 100 subjects and 49 are currently enrolled or have completed the study. Mean weight loss (regardless of randomization which is blinded until study end) is 1.7 kg.